The role of Alternaria fungal sensitization in asthma pathogenesis

PROJECT SUMMARY
ALTernaria ALTernata (ALT) is the most common outdoor airborne fungus found worldwide. The prevalence of
ALT sensitization ranges from 2% to 23.8% in the general population and much higher among asthmatics. ALT
sensitization has been associated with airway hyper-responsiveness, asthma and adverse asthma outcomes.
It is an enigma why some people develop sensitization to a common fungal allergen (ALT) while others don’t.
Moreover, the reason why ALT sensitization is associated with increased risk of developing asthma is not
known. In this proposal, we will explore the mechanisms and cell types that drive ALT sensitization and the
development of asthma. We recently identified a novel subset of house dust mite (HDM)-specific T cells
characterized by an interferon response (IFNR) gene signature (THIFNR cells), which was negatively
associated with HDM sensitization. In a pilot study, focussed in ALT allergen, we found that the proportion of
ALT-specific THIFNR cells was increased in healthy subjects without ALT sensitization when compared to
asthmatic subjects suggesting that it may also play a protective role in ALT-sensitization and asthma. We also
found that ALT-specific TH2 cells from asthmatics displayed pathogenic features that were distinct from HDM-
specific TH2 cells. Based on these findings, we hypothesize that ALT-specific THIFNR cells protect against
ALT-sensitization in healthy subjects, and a novel pathogenic TH2 subset in the airways, specifically tissue-
resident memory T cells (TRM cells) promote the development of asthma in ALT sensitized subjects. In Aim 1,
we will determine the association between ALT-specific THIFNR cells and protection against ALT sensitization.
We will assess subjects enrolled in the Isle of Wight Whole Population Birth Cohort. We will identify subgroups
of participants (n=100) with: (i) Persistent ALT-sensitization since childhood (n=25), (ii) Adult-onset ALT-
sensitization (n=25), (iii) HDM-sensitized without ALT-sensitization since childhood (n=25), and (iv) Non-
atopic since childhood (n=25). We will isolate ALT-specific T cells from blood and perform single-cell RNA-seq
and TCR-seq to enumerate the frequency, properties, persistence and clonality of ALT-specific T cell subsets,
including the novel THIFNR cell subpopulation, and determine their association with risk and protection against
development of ALT-sensitization at different ages. In Aim 2, we will identify ALT-specific T cell subsets in the
blood and airways associated with the development of asthma in subjects with ALT-sensitization. We will enroll
50 subjects with ALT-sensitization from the IOWBC (n=25 with asthma, n=25 without asthma), and as controls,
50 asthmatic subjects without ALT-sensitization (n=25 with HDM- sensitization, and n=25 with no sensitization
to common allergens), obtain blood and airway samples (sputum). We will perform single-cell transcriptome
and TCR-seq analysis to determine the frequency, properties, persistence and clonality of ALT-specific TH cell
and TRM subsets in the blood and airways, and their association with asthma.

Public health relevance
RELEVANCE WHO estimated that 20% of the world’s population suffer from aero-allergies making it the most common chronic non-infectious disease. Allergic response to fungal allergens like ALTernaria ALTernata (ALT), one of the most common fungi worldwide, is strongly linked to asthma. Here, we will perform studies to define the cellular basis of allergy and asthma that is related to a common airborne fungal allergen. Our studies will provide much needed insights for developing preventative and/or curative therapies for allergy and asthma.